A smoke-free home intervention in federally subsidized housing

PROJECT SUMMARY
The smoke-free home intervention study aims to reduce racial/ethnic disparities in tobacco use and exposure
by increasing access to smoke-free homes and cessation resources among racially/ethnically- and
linguistically-diverse populations in federally subsidized housing (“subsidized housing”). Black/African
American, Hispanic/Latino, and Asian populations with limited English proficiency are over-represented in
subsidized housing; these populations have higher rates of tobacco use and exposure than the general
population. Tobacco-related cancer and cardiovascular disease contribute disproportionately to the excess
morbidity and mortality in these populations. Comprehensive smoke-free policies have the potential to
substantially reduce tobacco-related disparities among populations in subsidized housing. In 2018, the
Department of Housing and Urban Development implemented a smoke-free policy in a minority of public
housing, presenting a unique opportunity to expand the reach of such policies to all types of subsidized
housing. This study fills this gap by identifying approaches to increase the implementation of smoke-free
policies in all types of subsidized housing by increasing the voluntary adoption of smoke-free homes and
promoting access to smoking cessation services. We will build on our pilot work, where we developed and
evaluated the feasibility of a smoke-free home intervention to increase voluntary adoption of smoke-free
homes in permanent supportive housing for formerly homeless adults. We adapted our previously-developed
smoke-free home intervention to federally subsidized housing by incorporating new intervention components
that align with racially-ethnically and linguistically-diverse populations in three geographically-diverse California
Counties. The multi-faceted intervention, delivered by bilingual study staff in Chinese (Mandarin and
Cantonese), English, or Spanish includes: 1) one-on-one counseling to residents who are smokers on how to
adopt a smoke-free home, and 2) training housing staff as lay health workers to deliver monthly brief cessation
coaching to residents. We propose to conduct a wait-list cluster randomized controlled trial of the adapted
smoke-free home intervention compared to usual care among N=544 residents from 24 subsidized housing
sites in Contra Costa, Oakland and San Francisco. Our specific aims are: Aim 1: To estimate the effect of our
adapted smoke-free home intervention on the primary outcome of residents' voluntary adoption of smoke-free
homes and the secondary outcome of biochemically-verified tobacco abstinence at 6-months follow-up. Aim 2:
To determine the cost of our adapted smoke-free home intervention and determine whether it is a cost-
effective use of health care resources. Aim 3: To evaluate variation in stakeholders’ perspectives on the
adapted smoke-free home intervention’s adaptability, scalability and sustainability. The proposed intervention
can expand access to smoke-free policies and smoking cessation services in subsidized housing, thereby
reducing racial/ethnic disparities in tobacco use, tobacco exposure and chronic disease in these populations.

Public health relevance
PROJECT NARRATIVE This study is directly relevant to the National Institute on Minority Health and Health Disparities’ mission to improve health equity by reducing the burden of tobacco use, tobacco exposure, and chronic disease among racially/ethnically diverse populations living in federally subsidized housing. We will conduct a wait-list cluster randomized controlled trial of our adapted smoke-free home intervention among racially/ethnically- and linguistically-diverse populations residing in federally subsidized housing, and leverage housing staff as lay health workers to support cessation behaviors among residents. This proposal has the potential to inform development of evidence-based strategies to increase implementation of smoke-free policies and smoking cessation services that can be brought to scale in federally subsidized housing in order to reduce tobacco- related health disparities.